IL-12 GENE THERAPY USING DIRECT INJECTION OF TUMORS

The objective of this phase I,II study is to define the local & systemic toxicity & immunmodulatory effects associated with peritumoral injections of fibroblasts genetically engineered to secrete IL-12 & evaluate the clinical efficacy of this procedure. A total of 18 patients with cutaneous cancer lesions of 4 types of cancer (melanoma, breast cancer, head and neck cancer and cutaneous T-cell lymphoma) will be enrolled in the preliminary study of this maximum tolerable or "possible" dosage study.